Adaptive population codes for flexible visually-guided behaviors

Summary/Abstract
Traditional models of visual information processing propose that stable perceptual and mnemonic
representations are supported by persistent activity in neurons that are selective for relevant stimulus features.
However, there is an emerging focus on the importance of reducing redundancy in neural codes to achieve more
efficient processing. For example, the visual system adapts to overall lightness levels and to frequently
encountered stimuli, allowing neural codes to maintain a useful dynamic range and to expend less energy
encoding expected stimuli. In addition to dynamics induced by recent stimulus history, recent work in machine
learning and in animal model systems reveals that codes also drift over short and long time scales, often while
preserving population-level geometric relationships between different stimulus representations. While many
factors likely contribute to this set of phenomena, here we focus on the general hypothesis that dynamics induced
by stimulus history and other factors support efficient yet error-tolerant codes. For example, recent work in our
lab suggests that the perceptual distortions induced by adaptation (e.g. the classic motion after-effect) are offset
by a flexible decoding scheme that utilizes a prior for temporal stability to compensate. Short-term dynamics,
particularly during visual working memory, at least partially reflect a reduction in the complexity of representations
so that only the most behaviorally relevant aspects of sensory information are retained to guide behavior. Finally,
long-term dynamics, or representational drift, may reflect a refining of neural codes to support increasingly sparse
information processing that is still robust to interference.
In the present proposal, we build on this recent empirical and theoretical work to evaluate the functional
role of neural dynamics driven by different factors across different time scales. We first test how the flexibility of
Bayesian read-out rules allows the visual system to counter the effects of stimulus history to produce continuous
and robust representation even in the face of internal and external noise. We then use recurrent neural networks
(RNNs) with different processing constraints to show that a drive toward sparser, and more energy efficient,
representations is sufficient to induce short and long-term drift in neural codes. Guided by these modelling efforts,
we will evaluate the impact of drift on neural codes as measured in human visual cortex using functional magnetic
resonance imaging (fMRI) and psychophysics, with a focus on testing hypotheses about the impact of drift on
the dimensionality and robustness of feature-selective activation patterns. Collectively, this work will challenge
traditional theories of perceptual inference, attentional selection, and working memory that are based on the
notion of stable neural codes by providing novel insights into the functional role that pervasive neural dynamics
play in visual information processing.

Public health relevance
Project Narrative Whether listening to a teacher in a classroom or driving a car down the road, the ability to perceive and remember the most important objects in the environment is critical to making situation-appropriate decisions. To achieve this goal neural codes must be efficient to ensure that processing resources are allocated to the task at hand and to free up unneeded processing resources to flexibly adapt as contextual factors evolve over time. Here we test the general hypothesis that cortical dynamics reflect the transformation of neural codes into more efficient, sparse, representations of just the most essential information needed to achieve behavioral goals.